Origins and Transformations of Signals for Circadian Regulation

PROJECT SUMMARY
The earth’s rotation drives profound changes in our environment. Practically every tissue of the body is
synchronized to this rhythm by an internal timekeeping mechanism, the circadian clock. Desynchronization
impairs mood, cognition, and physiology—commonly experienced in shift work and jet lag. Proper exposure to
light realigns the clock with the solar day and can reverse these impairments. We have developed a new
method to access the pathway that joins the eye with the master clock in the brain. We propose to define how
information is generated within the retina and subsequently transformed as it enters clock circuitry. We expect
to provide knowledge of how physiology is tuned to environmental cycles, and of the division of labor between
retina and brain.

Public health relevance
PROJECT NARRATIVE Dysregulation of the circadian clock is implicated in cancer, cardiovascular disease, metabolic disorder, and mental illness. The principal means of clock regulation is light acting through the retina. We seek to investigate the normal function of retinal cells and their communication with the master circadian clock, located in the brain, to understand the origin of circadian regulation and strengthen the basis of treating circadian dysfunction.